Reducing Mobility-associated Interruption in ART among Men in Malawi (ReMIT)

Project Summary/Abstract
Project: Despite advances in HIV treatment programs, marginalized groups, including mobile men, continue to
struggle to remain in care. Mobility is associated with worse antiretroviral treatment (ART) retention and viral
suppression throughout sub-Saharan Africa. However, mobility is an essential livelihood strategy for many men
living with HIV (MLHIV). In the ReMIT study (“Reducing Mobility-associated Interruption in Treatment among
Men in Malawi”), we will refine and pilot an intervention to improve ART outcomes among mobile MLHIV in
Malawi. In Aim 1, we will use qualitative data from MLHIV, healthcare workers, and a community advisory
board to refine an intervention including multi-month dispensing, a hotline for mobile MLHIV, and mobility-
specific counseling. In Aim 2, we will conduct a pilot cluster randomized control trial at 6 health facilities with
240 mobile male ART clients (n=120 per arm) to test the intervention refined in Aim 1. Outcomes include a
preliminary estimate of the intervention’s effectiveness on ART retention (6-month retention - primary outcome)
and acceptability and feasibility of the intervention. Results of the pilot will inform a future, definitive trial.
Candidate background: I am trained as a physician and board certified in Internal Medicine & Pediatrics and
am transitioning to a career in global health research. In addition to my medical degree, I have a master’s in
public administration in international development (MPA/ID) and have worked in Malawi, Mozambique, and
Kenya. Career goals: My long-term career goal is to become an independent investigator with expertise in
health system interventions to improve access to care among vulnerable populations in sub-Saharan Africa.
Career development plan: The proposed K01 award will provide protected time, practical experience, and
training resources to develop my skills in (1) health systems interventions, (2) mobile populations, (3) trial
design and analysis, and (4) ethics in global health research and decolonizing global health. Environment:
The study will be conducted as part of an ongoing collaboration between the University of California Los
Angeles (UCLA) and Partners in Hope (PIH), a medical and research organization, based in Malawi. PIH is the
prime awardee on a US President’s Emergency Plan for AIDS Relief (PEPFAR) grant to support 123 health
facilities throughout Malawi, providing staff mentorship and capacity building, treatment and care, and
monitoring and evaluation of HIV and TB services. PIH and UCLA have a 15-year relationship using a Multiple
PI model that has resulted in completion of 20 clinical trials and implementation science studies.

Public health relevance
Project Narrative Mobility, especially unexpected travel, puts men living with HIV in sub-Saharan Africa at risk of HIV treatment interruption and poor health outcomes. By refining and piloting an intervention to reduce treatment interruption among mobile men in Malawi, the proposed project will provide knowledge on how to improve treatment outcomes among this vulnerable population. The project has the potential to improve public health by improving viral suppression among mobile men living with HIV, a critical population in the effort to end the HIV epidemic.